Evaluating the contribution of senescent cells in a model of post-traumatic epilepsy

Abstract
Post-traumatic epilepsy (PTE) is a disorder defined by spontaneous recurrent seizures following a traumatic
brain injury (TBI), accounting for ~20% of the 3.5 million cases of epilepsy in the US alone. Currently, no
treatment given after a TBI has meaningfully impacted the development of PTE. This may be due to a limited
understanding of epileptogenesis, the process by which initial insults lead to chronic seizures. TBI causes DNA
damage, inflammation, and impaired synaptic plasticity. Epileptogenesis involves synaptic remodeling, circuit-
level changes, and cell death. Excessive inflammation and DNA damage also activate the cellular senescence
program, which activates in response to extreme stress or injury. Senescent cells (SCs) are impaired in their
normal functions, secrete a host of pro-inflammatory molecules, and are increasingly implicated in age-related
diseases. Our group has found that removing SCs halts epileptogenesis in a model of temporal lobe epilepsy,
but SCs are unexplored in the context of PTE.
The controlled cortical impact (CCI) is an highly reproducible model of TBI in rodents that generates
similar pathological features seen in humans. Following a CCI, mice develop memory deficits, sustained
neuroinflammation, impaired synaptic plasticity, spontaneous recurrent seizures, and SCs. Recent
modifications to the CCI model have dramatically increased the incidence of the seizure phenotype, which was
previously variable. I confirmed both the presence of SCs and the high incidence of seizures (63% of mice) in
the CCI model. Therefore, I hypothesize that removing SCs will prevent PTE.
To test this, I will use a well-characterized SC-ablating drug cocktail (senolytic), dasatinib and quercetin
(DQ). I will use DQ in the CCI model of PTE to assess the contribution of SCs in the development of PTE. I will
examine the effect of DQ at the cellular (transcriptome sequencing) and system (behavior and seizure
incidence) level in order to determine if and how SCs contribute to PTE pathology. By doing so, this study will
be the first to evaluate the efficacy of senolytic therapy in this model of PTE, shed light on the mechanisms by
which SCs promote epileptogenesis, and provide preclinical data for a novel prophylactic for PTE, an unmet
clinical need.

Public health relevance
Project Narrative I propose to use a preclinical rodent model of post-traumatic epilepsy to investigate the hypothesis that removing senescent cells will prevent the development of epilepsy following a traumatic brain injury. I will examine the impact of senescent cell ablation on the behavior, seizure burden, and transcriptomes of injured mice to determine if and how senescent cells drive pathogenesis. Senescent cells are a novel target in the context of post-traumatic epilepsy, and this research will evaluate a new avenue for prophylactic treatment, providing me with training to achieve my goals of being a physician scientist specializing in the pathophysiology of neural injury and degeneration.